NIAAA PUBLICATIONS AND EXHIBITS SUPPORT

The NIAAA Publications and Exhibits Support contract provides support for the creation and production of new and recurring NIAAA publications, updating of NIAAA’s existing materials, translation of new and existing NIAAA materials into Spanish and other targeted languages, management of NIAAA’s exhibits program, and warehousing functions for all the NIAAA publications and exhibits projects.